Administrative Core for Building Community and Research Opportunities

PROJECT SUMMARY/ABSTRACT - Cambridge Health Alliance
ALACRITY for Early Screening and Treatment of High Risk Youth (eSToRY)
Administrative Core for Building Community and Research Opportunities
The eSToRY Center brings together researchers from multiple disciplines in order to test innovative
approaches and train researchers in the community and within the healthcare system with an integrated
research and data infrastructure that will lead to timely and more effective interventions for mental illness. To
galvanize these efforts, the Administrative Core will develop and maintain an infrastructure for the planning,
coordination, integration, evaluation, and dissemination of multi-disciplinary, multi-site research and training
activities. The Administrative Core will also provide leadership, oversight and direction to the eSToRY Center
to improve training and research related to improving equity of screening and early mental health intervention
for youth in racial/ethnic and linguistic (REL)-minority communities.
In Aim 1, we enhance linkages between Cambridge Health Alliance's large, urban safety net healthcare
system with collaborating community and academic partners to stimulate community participation, facilitate
research, and identify and treat REL-minority youth at risk for mental illness. In Aim 2, we provide oversight
and support to three R34 projects and other pilot studies, facilitate use of the Methods Core, deploy state-of-
the-art disparities methods and rapid diagnostic data collection, and coordinate across multiple clinical and
community sites. In Aim 3, we support training opportunities for junior faculty, medical students, psychiatry
residents, PhD students and pre- and post-doctoral fellows interested in mental health care disparities
research and early intervention for youth, including the solicitation, review and implementation of two pilot
feasibility projects per year. In Aim 4, we disseminate and implement the findings of the eSToRY Center's
research activities to expand and improve the identification and interventions for REL-minority youth at risk for
mental illness, translating research findings directly into clinical practice and expanding research studies on a
national scale.